Portable Ankle Robotics to Reverse Foot Drop After Stroke.

Overall Project Summary
This proposal finalizes the design of a portable ankle robot as a therapeutic device to reverse foot drop and
restore safe independent walking after stroke, then conducts a rigorous randomized clinical trial to establish
clinical efficacy for this new market application. Product development is inspired by our five positive clinical
studies that demonstrate that ankle robot-mediated functional motor learning is most effectively conducted in
the context of locomotor task-oriented training. In Phase I, we pursued finalization of a lighter weight, battery
powered, and wirelessly controlled ankle robot (AMBLE) that meets basic clinical usability standards for regular
mobility-focused physical therapy (PT). Specific Phase I accomplishments include designing and bench testing
a functional beta prototype that meets key safety, stability, and comfort metrics during over-ground walking and
mobility tasks for full integration into PT. Phase II (3-yrs) is a blinded, randomized clinical trial investigating the
hypothesis that 9 weeks (18 sessions) of PTR is more effective than PT alone to reverse foot drop as
assessed by instrumented gait biomechanics and blinded clinician assessment. Our results will establish safety
and initial efficacy for reversal of foot drop as a new market application filling an unmet need, and shift care
toward PT-integrated robotic exoskeletons across other impaired joints.

Public health relevance
Supplement Project Narrative This supplemental proposal aims to address unforeseen challenges to study recruitment, staffing availability changes at our principal study site and Physical Therapy environmental changes. Each of these challenges are a result of the Covid-19 pandemic and shall be addressed by increasing our available participant trainers and contracting with an experienced recruitment firm to help drive eligible patients to our study site.